Intracellular Stress Inputs to SAPK Signaling Pathways

Summary
Stress-activated protein kinase (SAPK) signaling pathways respond to a wide variety of stress conditions,
including DNA damage, oxidative stress, heat shock, endoplasmic reticulum stress, hyper- and hypo-osmotic
stress, shear stress, and a growing number of chemical toxins. We are interested in two general questions.
First, how do diverse stressors activate a small number of evolutionarily conserved SAPKs? We have
developed evidence in Saccharomyces cerevisiae that a multitude of stress signals stimulate the two yeast
SAPK pathways – the Cell Wall Integrity (CWI) pathway and the High Osmolarity Glycerol (HOG) pathway –
through intracellular inputs at various points along these pathways, rather than signaling from the cell surface.
Second, how does the cell mobilize coherent, stress-specific outputs from an activated SAPK? The canonical
stress pathways respond to cell wall stress (CWI pathway) and high external osmolarity (HOG pathway), but
many stresses require the activated SAPKs to drive unrelated responses. We use the two SAPK pathways of
yeast as models for understanding the complexity of stress inputs to SAPKs, as well as stress-specific outputs
from activated SAPKs. This proposal is focused on identifying and characterizing the stress-specific
components and pathways that feed into the two yeast SAPK cascades. Aim 1 is to understand the role of
SAPK Hog1 in the intracellular activation of SAPK Mpk1 by heat shock. We have found that heat shock signals
both through the canonical CWI SAPK pathway and, independently, through a Hog1-dependent input to either
Mpk1 itself or its immediately upstream kinase, Mkk1. We propose a combined, biochemical, mass
spectrometric approach, together with a genetic screen to identify and characterize the pathway between Hog1
and Mpk1. Aim 2 is to identify and characterize intracellular inputs to the HOG pathway cascade by curcumin,
a promising cancer and Alzheimer’s therapeutic. We have identified two separate curcumin-induced inputs to
the Sln1 branch of the HOG pathway, one at the MEK kinase Ssk2 and the other at Ypd1, a component of the
HOG pathway phospho-relay. We propose a combination of biochemical and mass spectrometric approaches
and a genetic screen to identify novel pathway components to these two inputs. Aim 3 is to identify and
characterize the intracellular input to the HOG pathway by acetic acid stress. We have identified an input to the
HOG pathway from acetic acid that activates Hog1 either at the level of its MEK Pbs2, or at Hog1 itself. We
have also found that acetic acid stress is unusual in that it induces a stable interaction between Hog1 and its
MEK Pbs2. Our favored hypothesis is that this stress activates Hog1 through recruitment of a scaffold protein.
We propose a combination of biochemical and mass spectrometric approaches to understand the basis for
Hog1 activation by acetic acid, as well as the stress-specific Hog1 output elicited by this stress. Completion of
these aims will provide novel insights into the mechanisms by which these stress signals activate SAPKs.

Public health relevance
Project Narrative This project is focused on the identification of novel intracellular inputs to stress-activated signaling pathways. These inputs are critical to elicit the normal cellular responses to a wide variety of chemical and physical stress conditions, including heat shock, environmental toxins, and genotoxic stress. Such cellular responses help to maintain cellular integrity, metabolism, and genomic stability and are important in the treatment and prevention of cancer and other diseases.